Administrative Core

ADMINISTRATIVE CORE
Abstract
The Administrative Core provides overall leadership and management support to the Center, supports the work
of the cores, facilitates communication across cores and the broader CIRA community, conducts strategic
planning to identify new scientific direction and stimulate interdisciplinary research collaborations, and monitors
and evaluates the impact of the Center. The Core provides the fundamental infrastructure to facilitate the
achievement of CIRA goals and coordinates and integrates the activities of all CIRA cores. Implementation
Science (IS) will remain central to realizing CIRA's mission in the next five years and require a strong research
support infrastructure and sustained investment in institutional and community partnerships. The Administrative
Core will lead strategic planning with input from all constituencies to guide CIRA's transition to an IS focus
while assuring continued alignment of the Center's priorities with the expertise and interests of our scientists
and research partners. While supporting CIRA's regional efforts through the New England HIV Implementation
Science Network, established in 2014 with the Providence/Brown Center for AIDS Research, the Core will
continue to advance CIRA's mission at the national, and global levels. This includes coordinating CIRA's
research agenda with other NIMH-funded P30 AIDS Research Centers (ARC) through monthly ARC
teleconferences facilitated by CIRA that promote synergy across ARCs. An Implementation Science Steering
Committee will be formed with accomplished IS and HIV researchers including the new deans of Yale School
of Public Health and Yale School of Nursing, Drs. Sten Vermund, and Ann Kurth, both bringing extensive
international HIV research experience. The Administrative Core will facilitate the IS Steering Committee as well
as CIRA's other advisory bodies, the Executive Committee, External Advisory Board, and Community Advisory
Board. Dissemination is another vital role of the Administrative Core. The Core develops and implements
strategic communication approaches, using a wide range of social media and other information technology for
all CIRA activities, emerging HIV information and dissemination of CIRA supported research to the scientific,
policy and practice communities. The Administrative Core includes the Director and PI (Dr. Paul Cleary) who
provides overall leadership; an Executive Director (Elaine O'Keefe) who provides administrative and financial
leadership, and has responsibility for the implementation of strategic direction and Center-wide evaluation and
Continuous Quality Improvement; an Assistant Director for Administration (Kathryn Young), responsible for the
Center's administrative and fiscal affairs including management of daily operations; and an Assistant Director
for Information and Research Technology (Pete Donohue), responsible for directing the Center's information-
related activities including development, design, and maintenance of systems for managing databases and
websites; and an Executive Administrative Assistant (Elizabeth Capello). The Administrative Core is led by the
Senior Management Group (SMG), comprised of Dr. Cleary, Ms. O'Keefe and Ms. Young.